Molecular mechanisms underlying persistent effects of early life exposure on lung function and remodeling

Project Summary/Abstract
Exposures to aeroallergens and air pollution remain prevalent in young children, whose lungs are rapidly devel-
oping and growing. Such exposures may increase the susceptibility to developing asthma and other lung dis-
eases. Previous studies in non-human primate models of early life exposure, asthma and recovery showed that
co-exposure to ozone and house dust mite (HDM) between 1 month to 6 months of age leads to hallmarks of
asthma phenotypes in infant rhesus macaques (6-month cohort). Interestingly, following removal of exposures,
exposed animals continued to have abnormal lung growth and airway hyperresponsiveness when they reached
adolescence (36-month cohort). These long-lasting effects of early life exposure could be due to the epigenetic
imprints of exposures on gene expression. Although relationships between early-life exposure, epigenetic mech-
anisms, and persistent phenotypic changes in the lung have been supported by studies in humans and animal
models, direct evidence supporting causal relationships from a model resembling human early life development
is lacking and remains as a significant research gap. Our long-term goal is to understand the respiratory health
effects of air pollution and aeroallergen and design mechanistically-driven novel therapeutics for lung diseases.
The objective of this proposal is to characterize the impact of postnatal early-life exposure to HDM and O3 on
the lung epigenome and explore a mechanistic link between these changes and alveolar development and air-
way remodeling. Leveraging collected samples from established models and cutting-edge comprehensive epige-
nomic analyses, we will test the hypothesis that postnatal early-life exposure to ozone and HDM alters the
pulmonary epigenome and leads to changes contributing to persistent airway remodeling and abnormal lung
development. Aim 1 will determine the epigenetic mechanisms responsive to early-life exposure to ozone and
aeroallergen in the 6-month cohort of rhesus monkeys. Epigenetic changes induced by exposures and associ-
ated with phenotypic changes will be identified from lung tissues collected following the last exposure in rhesus
monkeys aged 6 months, and gene regulatory mechanisms underlying these changes will be inferred and pre-
dicted. Aim 2 will determine the epigenetic mechanisms underlying continued abnormal lung function and de-
velopment following early life exposures in the 36-month cohort. Lung tissues will undergo the same analyses
as in Aim 1, and differences between the exposed and control groups will be determined. Data from Aims 1 and
2 will also be integrated to provide a better understanding of the longitudinal impact of early exposures.
Comparative analyses to human asthma and mouse models of asthma may futher support the utility of non-
human primate models of asthma. Leveraging existing tissues from established models, this exploratory and
developmental R21 will provide new insights into the mechanisms of postnatal early-life lung development and
the impact of early-life exposure on airway and lung remodeling and may provide new preventative and thera-
peutic targets for lung diseases with an early life origin.

Public health relevance
Project Narrative The findings from our proposed studies will identify molecular mechanisms explaining the negative and persistent impact of postnatal early-life exposure to allergens and pollutants on lung inflammation and remodeling. This will provide new insights into the pathogenesis of asthma and other lung diseases and may fuel the development of new therapies.